INTERLEUKIN 6 AS A MARKER FOR BONE LOSS IN PRIMARY HYPERPARATHYROIDISM

We currently have 26 patients enrolled in this study, half of whom have been followed for one year. An interim analysis of the data are planned for 4/99.